Structure-Function of Nucleo-Cytoplasmic Communication

PROJECT SUMMARY / ABSTRACT
Eukaryotic cells are defined by their organelles, membrane-enclosed compartments in which specific cellular
processes are carried out. The nucleus is the largest organelle, contains all genetic material, and enables
separation of gene transcription from protein translation. As the nuclear envelope (NE) serves as a tight barrier
enclosing the nucleus, the cell requires machinery to establish and control nucleo-cytoplasmic communication.
There are two principally different components to this machinery. Nuclear pore complexes (NPCs) serve as the
main conduit for molecular exchange across the NE, while universally conserved linker of nucleo- and
cytoskeleton (LINC) complexes serve as physical tethers across the NE. LINCs are necessary for positioning
the nucleus and for mechano-sensing in a diverse set of circumstances. Dysfunction of the machinery is at the
core of important human diseases, including skeletal and cardiac myopathies, premature aging, and cancer. Our
goal is to understand the structure of the protein complexes involved in nucleo-cytoplasmic communication at
high (atomic) resolution. Such information helps to identify and separate the myriad functions this machinery
carries out and that we are still only beginning to fully grasp. High resolution information further provides the
basis for structure-guided drug design to interfere with the salient human diseases, such as Emery-Dreifuss
Muscular Dystrophy (EDMD) and Primary Dystonia, which are still not cured. The structural characterization of
the NPC and the LINC complex are challenging, because of the size and complexity of these multi-MDa
assemblies. Over the past 15 years, we have made significant advances on both problems. For the NPC, we
have chosen a highly productive bottom-up approach, in which we characterized multi-subunit complexes
predominantly by X-ray crystallography, the building blocks of the massive, 40-100 MDa NPC. Those structures
have now been used in combination with cryo-electron tomographic (cryo-ET) maps of assembled NPCs to
generate composite structures that can tentatively position the roughly 500 individual proteins within one NPC.
For the LINC complex, we solved the universally conserved core component and have started to untangle the
diverse network of its components, the Sad1/UNC-84 (SUN) and Klarsicht/ANC1/Syne-Homology (KASH)
proteins. Going forward, the challenge is the structural characterization of large and dynamic assemblies, which
is true for both, the NPC and the LINC complex, for the latter particularly when including the connection to the
nucleo- and cytoskeletal components. The dramatic advances in cryo-electron microscopy (cryo-EM) over the
recent past make this technology particularly important for our studies. We anticipate combining X-ray
crystallography and cryo-EM for studying the most relevant structures going forward. The success of this will
depend upon innovative methods to address the particular challenges that come with each project. We have
repeatedly shown how to successfully approach such challenges and have devised methods to meet them.

Public health relevance
Nucleo-cytoplasmic communication is an essential element of all eukaryotic lifeforms, including humans. Our goal is to provide the structural underpinning of the relevant machineries in the cell that facilitate and are involved in these processes, since such information leads to a mechanistic understanding and, most importantly, enables structure-guided drug design. Dysfunctional nucleo-cytoplasmic communication is at the core of diverse human diseases, including muscular dystrophies, cardiomyopathies, premature aging, and cancer.